Pelvic Floor Disorders Network Clinical Sites (UG1)

Project Summary/Abstract (30 lines of text) This application demonstrates the achievements and capabilities of the Pelvic Floor Disorders Unit (PFDU) of the University of Pennsylvania as a clinical site for the Pelvic Floor Disorders Network (PFDN). We detail our unique strengths that have allowed us to make significant academic, clinical and administrative contributions to the Network. We have a well-established research and multi-disciplinary clinical infrastructure including long-standing clinical and research relationships with urology, colorectal surgery, gastroenterology, advanced practice nursing, geriatrics, behavioral medicine, radiology, basic sciences and epidemiology and extensive experience in performing relevant clinical trials and observational studies both within and outside the PFDN Network. Our investigators have substantially contributed to all areas of clinical trial design and development, implementation, recruitment and retention and scientific reporting in the Network and presented outcomes of this research at national scientific meetings. We have an excellent track record of facilitation and cooperation with other network sites, the Data Coordinating Center, Advisory and Data Safety Monitoring Boards and participation as Chair of various committees. Specifically, Penn investigators are leading several active research protocols including 1) Treatment for Mixed Urinary Incontinence: Mid-urethral Sling vs. Botox A (MUSA, Harvie), 2) accidental bowel leakage severity association with dietary intake (NOTABLe Dietary Screener, Andy), 3) clinical and translational research in defecatory dysfunction (SMM-CAPABLe, Arya), and 4) cost-effectiveness analyses for all trials (Harvie). Our recruitment and retention in multi-center trials is outstanding and the result of an exceptional research infrastructure and culture of research that permeates all our clinical activities. Our unique geographical location allows us to recruit a large and ethnically diverse patient population from three states (Pennsylvania, New Jersey and Delaware). Additional unique strengths of the Penn site include 1) strong collaboration with Urology 2) a dedicated clinical research unit in the Department of OB/GYN that provides direct financial, logistical and personnel support beyond the PFDN budget 3) the Penn Clinical and Translational Research Center (CTRC) that provides PFDN investigators low cost access to all state-of-the art technologies. Ultimately, the team of investigators, available population, our cost-effective and efficient approach to clinical trials and outstanding university resources make the Penn PFDU an ideal site to advance the scientific productivity of the Pelvic Floor Disorders Network and we are committed to continuing these activities in this Administrative Supplemental bridge year.

Public health relevance
Project Narrative (3 sentences) Pelvic floor disorders are common, costly, and their prevalence is increasing in the United States; it is important to improve the care and individualized the treatment for the 1 in 4 US women with quality of life altering pelvic floor disorders. The Pelvic Floor Disorders Network supported by the Eunice Kennedy Shriver National Institutes of Child Health and Human Development has performed research for the evidence-based management of women with these conditions for over 20 years, and we are submitting an Administrative Supplemental bridge year proposal to highlight our abilities in order to continue to participate in this important initiative. Investigators at the University of Pennsylvania are committed to developing and testing innovative new treatments for urinary and fecal incontinence and pelvic organ prolapse through high quality clinical trials, and as a part of this application we provide information regarding our credible multi-disciplinary investigators and research experience, current research activities, track record of excellence in clinical research and strengths of our institutional infrastructure.